Native American Tribes Outreach, Education, and Training to Enhance Food Safety and FSMA Compliance: Tribal Food Safety Alliance

Project Abstract of the Indigenous Food and Agriculture Initiative at the University of
Arkansas: RFA-FD-23-032, Renewal-Native American Tribes Outreach, Education, and
Training to Enhance Food Safety and FSMA Compliance
To address these specialized needs, the federal Indian law and agricultural law experts
at the Indigenous Food and Agriculture Initiative (IFAI) at the University of Arkansas
have worked in partnership with the U.S. Food and Drug Administration (FDA), the
Intertribal Agriculture Council (IAC), and the University of Arizona's (UAZ) Federally
Recognized Tribal Extension Program (FRTEP) to establish the nation's ﬁrst Tribal Food
Safety Alliance (TFSA) through previous Cooperative Agreement. The TFSA was
established by IFAI, IAC, and UAZ in 2020 to fulﬁll the following stated objectives:
1) provide training, education, and outreach to Indian Country stakeholders on rules
promulgated by FDA pursuant to FSMA, with particular focus on the Produce Safety
Rule (PSR) and Preventative Controls for Human Food Rules (PCHFR); and
2) address gaps in training for this stakeholder audience; and
3) identify culturally sensitive technical assistants and educational materials that are
relevant to tribal produce growers, tribal food manufacturers.
Our overarching goal for TFSA has and continues to be providing Native growers and
food business owners across Indian Country with the kind of culturally appropriate
training, education, and outreach on food safety that will help them be successful in
the marketplace. This goal aligns well with FDA's goal through these agreements, to
enhance the fundamental knowledge of food safety and especially on-farm good
agricultural practices of tribal stakeholders subject to applicable FSMA regulations.

Public health relevance
Project Narrative of the Indigenous Food and Agriculture Initiative at the University of Arkansas: RFA-FD-23-032, Renewal-Native American Tribes Outreach, Education, and Training to Enhance Food Safety and FSMA Compliance The work of the Tribal Food Safety Alliance ensures that 80,000+ Tribal growers and Tribal Na>ons opera>ng food businesses have access to the specialized educa>on and training they need to promote food safe prac>ces in their opera>ons in a way that incorporates tradi>onal Indigenous food science and ways of knowing. This work is signiﬁcant to public health because it helps further a na>onal integrated food safety network that lessens the possibility of foodborne illness outbreaks causing sickness, impairment, and even death.